GENETIC POLYMORPHISMS IN NATIVE INDIANS IN MEXICO

It is the purpose of this contract to investigate several isolated Indian populations in Mexico. The opportunity to investigate isolated groups which have retained their cultural and genetic identity is rarely encountered. As little is known about the genetics of these populations many informative markers will need to be studied such as red cell antigens, immunoglobulin allotypes, and complement factors as well as the major histocompatibility complex. Areas which will benefit from this approach are anthropology, population genetics and epidemiology.